Philips Achieva upgrade to support Connectome-compatible data acquisition

PROJECT SUMMARY The overall purpose of this proposal is to upgrade a research-­dedicated, Philips 3T Achieva MRI scanner at the University of Washington Medical Center to support state of the art signal acquisition. The upgrade will incorporate a digital signal transmission system, a multi-­transmit system, and the Philips implementation of simultaneous multislice (multi-­band) acquisition. This upgrade will enable (i) a 15-­40% increase in signal-­to-­ noise ratio, (ii) increased RF homogeneity and low RF power deposition, and (iii) high spatial and temporal resolution for functional and anatomical imaging. Extensive neuroimaging research is conducted at this scanner, especially with functional MRI and supporting modalities, Research activity also encompasses cardiac MRI, fetal imaging, coil design and optimization, and advanced spectroscopy. The proposed upgrade will benefit essentially all neuroimaging research, in humans and animals alike, through a fundamental improvement in the fidelity (signal to noise characteristics) of the instrument. Imaging science has become simply critical, and increasingly so, for understanding biological systems, detecting and controlling disease, and translating basic discovery. The Diagnostic Imaging Science Center (DISC) and the closely partnered Integrated Brain Imaging Center (IBIC) are the necessary and primary neuroimaging resources for NIH-­funded investigators at the University of Washington, who are interested in brain organization and function in health and disease. The upgrade will enable them to advance multimodal (functional and diffusion connectivity, vascular and structural MRI) imaging methods in clinical populations, including children and elders with neurodegenerative diseases. Multiband acquisition will support superior spatiotemporal resolution in fMRI, make multi-­shell diffusion MRI feasible routinely, and enable Human Connectome Project-­ compatible data acquisition protocols that are becoming a standard requirement for some cognitive neuroscience programs. The scanner is housed at DISC and maintained under the supervision of expert MRI physicists and technologists. We have outlined a detailed financial, technical, and safety plan for the smooth operation of the scanner. Institutional commitment includes the differential costs required in excess of the grant award to complete this upgrade.

Public health relevance
NARRATIVE The proposed upgrade of a research dedicated Philips MRI scanner will scientifically benefit all users of a productive and integrated MRI facility dominated by NIH- funded investigators. It will fundamentally improve the level of inquiry possible in cognitive and systems neuroscience. The emergent capabilities, especially multiband acquisition, are critical to the competitiveness of scientists investigating the organization of the brain in health and disease.